Human Studies Consultation Core

NORTH CAROLINA DIABETES RESEARCH CENTER (NCDRC): HUMAN STUDIES CONSULTATION CORE
SUMMARY
The context in which we do diabetes research is changing rapidly with increasing access to wearable
technology and remote monitoring, and data for real world evidence generation from electronic medical records
and claims data. New technologies bring immense new opportunities, but also limitations and logistical
challenges different from more traditional approaches. While these tools can help overcome barriers to
measurement, access to participants from underserved groups, and novel phenotyping, they are not readily
available to those without prior expertise. The Human Studies Consultation Core (HSCC) of the North Carolina
Diabetes Research Center (NCDRC) was planned specifically to bridge the translational gaps in the T2-T4
pipeline by overcoming the divide between clinicians and population researchers in determining the optimal
implementation of these technologies to improve outcomes in people living with diabetes and for prevention in
those at risk. During its first year the HSCC was successful at implementing multiple consultative service areas
to meet these goals. In the next funding cycle the HSCC will refocus on the services most needed by the
NCDRC membership by 1.Building strength for existing services, 2. Extending to complementary services, 3.
Developing synergy with the new Bench to Bedside Consultative Core (B2C2) to ensure that translational
steps are available across the full range of the scientific spectrum, and 4. Continuing to expand support for
inclusion of under-represented groups as an overarching goal. To meet these goals the HSCC proposes the
following specific aims: Aim 1: Strengthen existing consultation services to support A. Use of continuous
glucose monitors in research, and B. Robust Real World Evidence generation, including electronic health
record and claims data. Both service areas will include guidance on advanced study design and analytic
methods, as well as practical concerns. Aim 2: Implement, expand, and integrate consultation services
for A. Other wearable devices and remote monitoring options, B. Methods for machine learning, artificial
intelligence, multisensory processing and other data science methods for research using claims, EHR, and
wearable or remote monitoring technologies, and C. Connections between B2C2 and HSCC cores to provide a
more seamless transition across the translational spectrum to help investigators bridge the gaps from T0 to T4.
Aim 3: Track utilization and user satisfaction to evolve with needs of the NCDRC membership. An
overarching goal across these aims is to foster opportunities for the appropriate inclusion of underrepresented
populations in diabetes research. The HSCC will improve the robustness of research performed at the NCDRC
and accelerate its translation into better treatments, cures, and preventive strategies for patients and
populations with diabetes. Added value will be provided through free consultation and concierge services,
amplified through cross-institutional collaborations facilitated by the three CTSAs.

Public health relevance
NORTH CAROLINA DIABETES RESEARCH CENTER (NCDRC): HUMAN STUDIES CONSULTATION CORE NARRATIVE The NCDRC initiated the Human Studies Consultation Core (HSCC) to provide several services focused on consultation for wearable devices and real world evidence, including claims data. Consultants will use their knowledge of available resources, especially those included in our CTSA sites to promote clinical translation for NCDRC investigators. Each area will include consideration of advanced methods, approaches for bias reduction, and opportunities for the appropriate identification and inclusion of underrepresented populations in diabetes research.